The role of Sonic hedgehog signaling in cranial neural crest potency

Project Summary/Abstract
Cranial neural crest cells (CNCCs) form most of the craniofacial complex. Despite being derived from an
ectodermal population, CNCCs are able to differentiate into both non-ectomesenchymal (e.g., neurons/glia) and
ectomesenchymal derivatives (e.g., bone, cartilage, and smooth muscle). This unique ability to form a broad
range of cell types from more than one germ layer has led to CNCCs being called “pleistopotent.” However, the
signaling mechanisms that convey this pleistopotency and drive differentiation of CNCCs are not well
understood. The Sonic hedgehog (Shh) signaling pathway has long been studied in the context of craniofacial
development. The Shh signaling pathway is mediated by bimodal Gli transcription factors (Gli TFs), which
activate or repress target genes associated with proper craniofacial development. Studies done on CNCC in
vitro demonstrated that exposure to recombinant Shh protein increased CNCC potency by increasing the
proportion of CNCCs that differentiated into both non-ectomesenchymal and ectomesenchymal derivatives and
decreased the proportion of CNCCs that only differentiated into non-ectomesenchymal derivatives. To test the
role of Shh signaling in CNCC potency, we generated a conditional mouse line lacking Gli activity in CNCCs
(Gli2f/f;Gli3f/f;Wnt1-Cre). Single cell RNA-sequencing analysis showed that E13.5 Gli2f/f;Gli3f/f;Wnt1-Cre CNCCs
were not separated into distinct clusters as compared to the wild-type CNCCs. Interestingly, while
ectomesenchymal clusters were poorly defined molecularly, non-ectomesenchymal clusters were relatively
unaffected. Thus, these data suggested that loss of Gli TFs led correlated with a loss of pleistopotency. Based
on these preliminary data I hypothesize that Gli-mediated Shh signaling conveys CNCC potency via activation
of pluripotent programs and that loss of Gli2/3 signaling limits potency, thus preventing differentiation into the full
range of CNCC derivatives. In Aim 1, I will perform CUT&RUN for Gli2 and Gli3 on embryos during CNCC
induction to look for binding of Gli TFs at traditional pluripotency markers. I will perform single cell RNA-
sequencing on both wild-type and Gli2f/f;Gli3f/f;Wnt1-Cre embryos before, during, and after CNCC induction and
specification and compare gene expression profiles to determine if loss of Gli TFs affects expression of potency
factors in CNCC, which I will validate with RNAscope. Finally, I will perform Western blots for Gli2 and Gli3 to
determine if Gli TFs are predominantly functioning as activators or repressors during CNCC induction. In Aim 2,
I will determine if loss of Gli TFs restricts fate commitment of CNCCs. I will generate Gli2f/f;Gli3f/f;R26R-Confetti+/+;
Wnt1-Cre embryos, where Wnt1-Cre drives Cre-recombination before establishment of CNCC pleistopotency,
and Gli2f/f;Gli3f/f;R26R-Confetti+/+;Sox10-Cre embryos, where Sox10-Cre drives Cre-recombination after
establishment of CNCC pleistopotency. This study is important for advancing our understanding of the unique
potency of CNCCs in craniofacial development and the knowledge generated in this proposal may be applied to
generate reparative tissues for patients with craniofacial defects or injuries.

Public health relevance
Project Narrative Cranial neural crest cells (CNCCs) are a multipotent population of cells that differentiate into a variety of cell- types including bone, cartilage, and neurons of the craniofacial complex. This proposal will explore the molecular signals that contribute to establishing CNCC potency. Knowledge gained from this proposal could be applied to generate tissues amenable for surgical repair of craniofacial malformations and injury.